Scalable Phenotyping to Assay Risk in Childhood after eXposures in Pregnancy: SPARC-XP

PROJECT SUMMARY
Infection in pregnancy is a significant risk for neurodevelopmental disorders in offspring, demonstrated
in national registries, large epidemiologic studies, and electronic health records cohorts. Mechanistic studies in
animals have similarly established adverse effects of maternal infection on offspring neurodevelopment and
behavior. Despite this compelling evidence of risk, at present there are no validated methods to predict which
exposed children will develop autism, ADHD, or other adverse outcomes. Better risk stratification methods are
urgently needed to guide early intervention.
Developing reliable, generalizable risk prediction requires large, representative populations and the
ability to conduct low-cost phenotyping, valuable in extending the prediction afforded by electronic health records
alone. This concept represents the crux of the IMPACT-MH initiative and the organizing principle of this proposal,
which seeks to fill a key knowledge gap in predicting neurodevelopmental outcomes. This study will generate
risk models to predict neurodevelopmental outcomes by age 8 among offspring of mothers with infections during
pregnancy, focusing on two actionable time points: at birth, and between ages 3 and 5. It will first use standard
and emerging machine learning methods to analyze electronic health records (EHR) data from at least 150,000
maternal-offspring dyads across 2 health systems, characterizing maternal infections, pregnancy complications,
and offspring phenotypes. These EHR data will be augmented by prospective phenotyping of 750 infection-
exposed children enrolled across 2 sites: MassGeneral Brigham health system in Massachusetts, and Vanderbilt
University Medical Center in Tennessee. The investigators will collect parental report of developmental data,
accelerometry data to assess motor function and sleep, and will perform virtual neurocognitive testing at age 3-
5 years. They will compare risk stratification models using electronic health records augmented with natural
language processing, parental reports, neurocognitive testing, and accelerometry. Children will again be
assessed at age 6-8 years to ascertain diagnoses. Optimal prediction models from the Massachusetts cohort
will be externally validated in the Tennessee cohort.
Together, these aims will yield tools for risk stratification in children exposed to maternal infection during
pregnancy, applying innovative methods to electronic health records integrated with remote behavioral
phenotyping. The project will be led by principal investigators with expertise in pregnancy exposures, large-scale
electronic health records, machine learning, and neurodevelopmental phenotyping.

Public health relevance
NARRATIVE Maternal infection during pregnancy is a risk factor for neurodevelopmental disorders in offspring. Drawing on two large birth cohorts identified from electronic health records, this study will examine early markers of risk among children age 3-5 who were exposed to infection during pregnancy, as predictors of a neurodevelopmental diagnosis at age 6-8. The ability to estimate risk will help to develop and target early interventions to prevent common disorders that have a major public health impact.